Core 1: Biological Correlation and Analysis Core

PROJECT SUMMARY – BIOLOGICAL CORRELATION AND ANALYSIS CORE (CORE 1)
The Biological Correlation and Analysis Core (Core 1) will focus on the biological evaluation of anticancer
natural products that are identified from complex extracts, and after subsequent isolation, confirmed to be the
active constituent. This strategy, called bioassay-guided isolation, facilitates the identification of biological activity
within complex mixtures from plants, fungi, and cyanobacteria. The overarching goal of Core 1 is to determine if
novel natural products are cytotoxic in cancer cells, decipher the pathways that they impact in the cancer cell,
identify their molecular target, and test their potency in vivo. The biological core of the Program Project Grant
(PPG) collaborates directly with all three projects and the Medicinal Chemistry and Pharmacokinetics Core
(Core 2) to test the antitumor properties of extracts, fractions, and compounds and then prioritizes leads for the
design and execution of specific strategies to move compounds into preclinical testing. Core 1 has successfully
used these strategies on numerous compounds including phyllanthusmins, verticillins, rocaglamides, cardiac
glycosides, eupenifeldin, aulosirazole, and wheldone. Because natural products are often isolated in small
quantities and these compounds have diverse biological activities, the Core does not use a one-size-fits-all
approach, and instead employs tailored plans. Projects collaborate in these approaches because the structures
and abundance often dictate access to semi- or total synthesis as well as help inform biological mechanisms.
Core 2 synthesizes compounds and analogs focused on enhancing potency or providing the material for target
identification by biotinylation or photoaffinity probe development. RNA sequencing and proteomics integrated
with the bioinformatics core provides context for the molecular pathways modified after treatment with the natural
products, which helps decipher if compounds would be useful in chemoresistant models or as a combination
therapy. Core 2 directly feeds into Core 1 as they confirm dosing and formulations that increase the chance of
identifying in vivo activity. Xenografts and syngeneic models are used to test the role of anticancer compounds
against human tumors and in the presence of an intact immune system. Overall, Core 1 tests all compounds
from the Projects as well as those made in Core 2 for in vitro and in vivo activity. Data are then integrated fully
with Core A for biostatistical analysis.

Public health relevance
PROJECT NARRATIVE – BIOLOGICAL CORRELATION AND ANALYSIS CORE (CORE 1) The overarching goal of this Program Project is to isolate novel agents from natural sources for the treatment of cancer. The Biological Correlation and Analysis Core (Core 1) will provide biological testing using a variety of molecular, cellular and animal-based systems to identify promising leads for further development. Core 1 will obtain materials for testing from each of Projects 1-3, work with Core A on biostatistical analysis, and identify leads that Core 2 can modify synthetically to enhance activity and investigate for pharmacokinetic and other parameters as candidate drug leads.